Quantification of neonatal transport networks through network analysis: a new approach to studying neonatal regionalization

PROJECT SUMMARY/ABSTRACT
Sarah N. Kunz, MD, MPH is a neonatologist at Beth Israel Deaconess Medical Center (BIDMC) and an
Instructor of Pediatrics at Harvard Medical School (HMS). Dr. Kunz's research and career plans focus on
developing novel and quantitative ways of defining and studying neonatal referral networks and ultimately
optimizing these systems to improve quality of care. Outcomes for very low birth weight (VLBW; <1500 grams)
babies are highly variable across the United States, arising in part from differential implementation of
regionalization, which prioritizes targeting high-risk births at hospitals that can provide adequate care. When
VLBW infants are born at hospitals without advanced neonatal intensive care, they require transport to a
higher-level center, increasing their risk of death and disability. Current tools to measure transport quality are
limited to easily measurable characteristics such as transport distance and team composition. More
sophisticated methods are required to understand how unmeasured aspects of neonatal transport influence
outcomes: specifically, how transports function in the context of the larger hospital referral network and how
the strength of hospital relationships affects outcomes. In this application, Dr. Kunz proposes applying network
science methods to linked clinical and transport datasets to analyze the VLBW transport network in California,
with particular attention to the effect of transport quality and network characteristics on outcomes. The specific
aims of this study are to: (1) characterize and quantify acute neonatal VLBW referral networks and transport
characteristics; (2) empirically define “cohesion” of VLBW infant transport networks; (3) test the association
between network cohesion and transport quality and outcomes; and (4) optimize transport networks. To
achieve these aims and further her long-term career goal of becoming an independent health services
researcher focused on improving care delivery systems, Dr. Kunz has constructed a career development plan
combining intensive mentorship, hands-on research experience, and didactic coursework. The oversight of her
expert mentors, along with courses in network analysis, advanced statistical methods, health policy, and
organizational culture, will build on the strong foundation she gained from her fellowship in health services
research and her Master of Public Health. Her institutional environment bridges two strong academic settings
(BIDMC/HMS and the California Perinatal Quality Care Collaborative/Stanford University). Upon completion,
the proposed research will elucidate the contribution of patient-, hospital-, transport-, and network-level
characteristics to the functioning of neonatal referral systems, and identify concrete approaches for systems-
level improvement, methods that will be applicable to other types of patient referral systems. Undertaking the
proposed project and career development activities are essential for Dr. Kunz to transition to an independent
health services researcher focused on optimizing care for infants by improving the systems that care for them.

Public health relevance
PROJECT NARRATIVE Care and outcomes for the more than 300,000 very low birth weight (VLBW; <1500 grams) infants born in the United States each year are highly variable, due in part to more than a quarter of these infants requiring inter- hospital transport to receive necessary care. Neonatal transport results in increased morbidity and mortality, and has previously been studied in isolation, rather than considering how transports function within the context of their larger referral networks to impact neonatal outcomes. By applying novel network analysis methods to neonatal transport networks, this study will provide the first direct, quantitative understanding of how hospital referral network structure interacts with patient, hospital, and transport factors to influence patient outcomes, thus providing administrators and policy makers with opportunities for improvement in quality of care.